Yale Cooperative Center of Excellence in Hematology

RESEARCH SUMMARY
The mission of the Yale CCEH is to facilitate, enhance, and promote research in hematopoiesis, stem cell
biology, and other nonmalignant hematology-related areas. The YCCEH’s unique focus is the application of
innovative, emerging technologies to study of normal and perturbed hematopoiesis. We have recently made
substantial progress towards the mission with three technology cores (Cell Prep, Imaging and Animal) that have
led to nonmalignant studies published in high impact journals, supported awarding of major grants, and trained
the next generation of nonmalignant hematology researchers. We now propose to add further cutting edge
technology and much needed clinical samples to the basic cores to further enhance studies and innovation.
Specific Aim #1 will add single platelet characterization to complement the technologies provided by the Cell
Preparation and Analysis Core. Specific Aim #2 will complement the Animal Modeling Core with key human
nonmalignant hematology samples and Specific Aim #3 will add the most recent FLASH-PAINT technologies to
the Imaging core. All these additions have been recently peer reviewed and published in high impact journals.
To continue the success of the YCCEH, technology and resources must evolve to be at the forefront of discovery.
The current administrative supplement proposal will maintain YCCEH as an international leader in technology
resources for nonmalignant hematology research.

Public health relevance
PROJECT NARRATIVE Technology to study nonmalignant hematology is rapidly evolving. To enhance the Cell Preparation and Analysis Core, we propose to add cutting edge methodology in CYTOF and single cell cytokine release assessment and analyses. To enhance the Animal Modeling Core, we propose to add a repository of bone marrow and blood samples from patients with nonmalignant hematological diseases. To enhance the Imaging Core, we propose to add assistance and training in FLASH-PAINT for assessing unlimited numbers of antigens on a single cell using immunofluorescence. By continuing to provide training in cutting edge technologies largely, and recently developed at Yale, to the broad non-Yale biomedical community, we aim to foster paradigm shifting breakthroughs in nonmalignant hematology.